Intramolecular Allosteric Regulation of SIRT1 Deacetylase Activity by the N-terminal Domain

Project Summary This project aims to elucidate the mechanism for intramolecular regulation of SIRT1 activity by the N-terminal domain of SIRT1, a conformationally dynamic region distal to the catalytic core. SIRT1 is an NAD+-dependent protein deacetylase which has been shown to play a significant role in many biological pathways, such as insulin secretion, tumor formation, lipid metabolism and neurodegeneration. For this reason, SIRT1 has been identified as a potential therapeutic target, where the regulation of SIRT1 activity could combat diseases such as diabetes, cancer and neurodegenerative diseases. This progress has been hampered by insufficient understanding of the molecular mechanism of the regulation of SIRT1 activity, as the C-terminal and N-terminal domains within SIRT1 play a complicated role in allosterically affecting SIRT1 activity. The N-terminal domain has been shown to potentiate SIRT1’s enzyme activity; this region also contains the STAC binding domain (SBD), a binding site for sirtuin activating compounds (STACs). However, there is limited in vitro biochemistry study on the N-terminal domain and its role in SIRT1 mechanism. Our project is focused on understanding the allosteric interactions between the N-terminal domain and SIRT1’s catalytic core using three independent aims that focus on conformational changes, specific key residues and binding events. Various structures of SIRT1 complexed with different ligands have shown the SBD in different orientations, suggesting a conformational flexibility of this domain. However, detailed studies linking the N-terminal domain conformation with enzyme activity are lacking. We will study this relationship by taking advantage of the substrate-specific SIRT1 regulator, resveratrol (Aim 1). A distinct allosteric switch region within the N-terminal of SIRT1 has yet to be experimentally defined. To this end, we will identify allosteric switch regions within the SIRT1 N-terminal domain (Aim 2). Additionally, an intrinsically unstructured region in the N-terminal domain, motif A, has been shown to bind to the SBD and potentiate SIRT1 activity as well, but the interaction parameters such as dissociation equilibrium constants have not been defined. We will further investigate this binding interaction in vitro and study the effects of phosphorylation at motif A on its ability to affect SIRT1 activity (Aim 3). Our studies will afford a more detailed understanding of the allosteric regulation of SIRT1 elicited by the N-terminal domain. This would clarify how the activity of SIRT1 is altered in various biological pathways and disease states, guiding a more targeted approach in modulating SIRT1 activity as a therapeutic method. It would also provide insight into how other allosterically regulated enzymes function in the cell.

Public health relevance
Project Narrative This project aims to better understand the molecular mechanism of how the activity of a lysine deacetylase, SIRT1, is affected by a domain in the enzyme itself. SIRT1 has been shown to play a role in many biological pathways, and altering the activity of SIRT1 has been explored as a therapeutic approach for treating diseases such as cancer, diabetes and neurodegeneration. We propose to gain a more complete understanding of how the activity of SIRT1 is regulated by its own internal domain, which will afford insight into the role that SIRT1 plays in the context of complicated biological pathways and guide therapeutic targeting of SIRT1.